Optimizing Nutrition for Maternal, Newborn and Child Health

ABSTRACT Support is requested for a Keystone Symposia conference entitled Optimizing Nutrition for Maternal, Newborn and Child Health, Growth and Development organized by Drs. Emily Smith, Anura Kurpad and Farhad Imam. The conference will be held in New Delhi, India from October 21-24, 2021. Maternal undernutrition leads to adverse pregnancy outcomes and poor fetal growth. Together, maternal and child undernutrition are responsible for nearly half of all child deaths globally. The first 1,000 days, including fetal life and early infancy, are key periods of growth and organogenesis. Nutrient availability during this time influences growth, development, and metabolic programming which also has implications for health and disease in later infancy and childhood. Despite the clear biological importance of maternal and newborn nutrition, our understanding of the basic biology linking nutrition to healthy growth and development is poor. Furthermore, research into innovative approaches to improving maternal nutrition and enhancing nutrition for vulnerable infants and newborns is lacking. This Keystone Symposia conference brings together population health scientists, clinical trialists, placental and breastmilk biologists, and experts in modern molecular and metabolic methods to address the unique nutritional challenges of women and infants in low- and middle- income countries (LMIC)s. This conference will encourage interdisciplinary research in maternal/fetal, newborn, and early infant nutrition, an area which has been understudied. It will also connect global nutrition and molecular nutrition experts for future collaboration. Finally, this conference is part of the Keystone Symposia Global Health Series, supported by the Bill & Melinda Gates Foundation.

Public health relevance
PROJECT NARRATIVE While global progress in reducing maternal and child mortality from poor nutrition has been remarkable over the last few decades, progress towards reducing adverse birth outcomes and related newborn morbidity and mortality has been stagnant. This conference seeks to highlight the global burden of disease related to poor nutrition for women and infants, as well as the prioritized opportunities for designing and testing innovative solutions across the life course. Ultimately, the conference seeks to bring together experts on the emerging basic science, innovative methods, and landmark clinical trials to advance the field of global nutrition and improve the lives of women and children globally.